Preclinical investigation of PI3K inhibition and immune checkpoint blockade combination therapy for treatment of Merkel cell carcinoma using humanized mouse models

Merkel cell carcinoma (MCC) is an aggressive skin cancer that has quadrupled in incidence with a dismal five-
year survival rate of less than 18% in advanced diseases. MCC disproportionately and predominantly affects
Caucasian males older than 65 who are well represented in our Veteran population, especially for those who are
deployed to high UV index tropical and subtropical zones and are not well protected due to other survival
priorities. Hence, MCC has a growing impact on the VA healthcare system. Currently, there is no Food and Drug
Administration (FDA)-approved targeted therapy for MCC. Recently, immunotherapies such as pembrolizumab
and avelumab have been FDA-approved for advanced MCC; nevertheless, a significant portion of patients still
succumb to their diseases. Thus, there is an urgent clinical need for novel therapeutic strategies for patients who
fail out of or are unsuitable for immunotherapy. Aberrant amplification and mutations of PI3K pathway have been
detected in up to 80% of MCCs, making it an attractive therapeutic target. This is supported by our clinical
success in treating a Stage IV MCC patient with the 1st FDA approved PI3K- inhibitor idelalisib, which elicited a
complete clinical response. Furthermore, our preliminary studies demonstrate that copanlisib, the 2nd FDA
approved PI3K inhibitor with activity predominantly against PI3K-α/ isoforms, exerts the most potent antitumor
growth effects on MCC. Of relevance to this proposal, PI3K inhibition has been reported to enhance cancer
immunotherapies. Thus, there is a strong rationale to develop new combinatorial immunotherapy with targeted
therapies to boost therapeutic response and efficacy in MCC. Lack of syngeneic/genetically engineered animal
models has hampered preclinical studies in MCC. Notably, in our preliminary studies we have successfully
established a powerful, clinically relevant model system of MCC xenograft tumors in mice with competent human
immune systems. We hypothesize that PI3K inhibition by copanlisib and PD-1 blockade by pembrolizumab will
synergistically attenuate MCC tumor growth by inhibiting MCC cell proliferation and survival and enhancing
tumor-infiltration of immune cells and their antitumor activities. Furthermore, we have optimized innovative
single-cell RNA sequencing (scRNA-seq) methods to examine tumor heterogeneity and transcriptome profile in
human MCC cells. Therefore, we are well positioned to pursue the following specific aims: (Aim 1) examine
therapeutic efficacy and identify underlying mechanisms of copanlisib and pembrolizumab therapies on MCC
xenograft tumor growth in humanized mice, and (Aim 2) identify cellular and molecular mechanisms of MCC
tumor-immune interactions and antitumor immunity in response to copanlisib and pembrolizumab treatments.
Using our novel MCC humanized mouse models, we will be able to examine, for the first time, tumor-immune
response to copanlisib and pembrolizumab under competent human immune system. Importantly, tumor
heterogeneity is a critical determinant of therapeutic failure and tumor progression. Recent advancements in
scRNA-seq enable us to explore dynamics of tumor and immune cell subpopulations in response to treatments.
To achieve our goals, we will utilize state-of-the-art biotechniques to comprehensively analyze the effects of
copanlisib and pembrolizumab treatments on tumors and antitumor immunity at tissue, cellular, and molecular
levels. We expect that successful completion of the proposed work will result in the following advances: (1)
establishment of a novel treatment paradigm for combinatorial therapies in MCC, as well as other cancers that
affect our Veterans and their family members such as melanoma and high-risk head and neck squamous cell
carcinoma, (2) identification of tumor and immune cell subpopulations that mediate drug response, as well as
biomarkers for sensitivity/resistance to copanlisib and/or pembrolizumab treatment, which can lead to future
discovery of effective therapeutic strategies. Knowledge gained from the proposed studies will validate and
accelerate clinical translation, which will help Veterans who suffer from MCC and cancers for which current
immunotherapies are insufficient.

Public health relevance
Notwithstanding recent success in immunotherapy, Merkel cell carcinoma (MCC) is often-lethal, especially if not diagnosed and treated at an early stage. To date, there is no Food and Drug Administration-approved targeted therapy. The proposed study will fill this gap by developing effective combinatorial strategies for advanced MCC based on our clinical success and preclinical findings. Using our novel humanized MCC mouse model, we will be able to examine, for the first time, the effects of combination immunotherapy and targeted therapy on tumor growth, tumor-immune interactions, and drug response in competent human immune system. In this proposal, we will apply state-of-the-art biotechniques to examine tumor-immune interactions, dissect tumor and immune cell heterogeneity and identify subpopulations/regulators mediating drug response and tumor progression. Knowledge gained from the proposed studies will validate and accelerate clinical translation, helping Veterans who suffer from MCC and cancers for which current immunotherapies are insufficient.